Novel Approaches to Adjusting for Population Heterogeneity and Representation in Neuroimaging Studies

Abstract
Big data featuring neuroimaging information collected from large population-based samples have spurred the
emergence of population neuroscience research. However, traditional methods for neuroscience research are
based on nonrepresentative samples that deviate from the target population, such as convenience and volunteer
samples. The lack of representativeness may distort association studies of brain-cognition mechanisms. This
proposal is motivated by the research team's collaborative work on the Adolescent Brain Cognitive Development
Study, which presents these common problems in empirical neuroimaging studies, to ﬁll the gap in statistical
methodology between survey and neuroscience research. The proposal develops new strategies to adjust for
nonrepresentativeness in association studies with complex and nontraditional survey designs, and to quantify
the potential impact of sampling features on statistical and substantive inferences. The overall objectives are to
identify population heterogeneity in the association studies between imaging and cognitive ability measures and
generalize multilevel regression and poststratiﬁcation as a robust framework for inferences based on nonprobabil-
ity samples. The software delivery with computational scalability and step-by-step guidelines will provide practical
recommendations and tools to map the relationships and adjust for selection bias when making population in-
ference. This interdisciplinary project will strengthen the validity and generalizability of population neuroscience
research, deepen new association understandings of brain and cognition, and facilitate policy intervention.

Public health relevance
Narrative The proposed research integrates survey methodology with neuroscience research and presents new statistical strategies to identify population heterogeneity and adjust for selection bias in neuroimaging association studies. The aims focus on building a robust framework for population-based inferences with nonprobability samples. This work will result in analytic developments and computational software to advance public health and social research, ultimately enhancing the reliability and reproducibility of population neuroscience research.